Cranial Osteopathic Manipulative Medicine Enhances Brain Fluid Flow Alleviating Neuroinflammation

PROJECT SUMMARY/ABSTRACT
Osteopathic manipulative medicine (OMM) has been used clinically to improve the quality of life for several
medical conditions and injuries; however, limited data is available on the brain’s response to this innovative
treatment. Cranial OMM (cOMM) involves the gentle application of manual force to the head and the axial spine,
subsequently affecting the patient by releasing soft tissue restrictions. This technique enhances motion of the
tissues and fluid flow through the brain through natural channels and helps to regulate tissue fluid flows in the
body as well as balancing the autonomic nervous system. We expect that cOMM will help to clear inflammatory
molecules from the brain in clinical challenges such as traumatic brain injury (TBI). To elucidate the mechanistic
effects of this integrative health approach utilizing cOMM, studies will focus on the cholinergic system. Multiple
studies and preliminary data consistently demonstrate that significant dysregulation in cholinergic
neurotransmission mechanisms occurs in injured rodent brains, which is intricately linked to neurological
phenotypes such as cognitive impairment and other neurologic dysfunctions. This underscores the profound
importance of exploring the therapeutic potential of cOMM in mitigating these adverse effects. There is a critical
need to ascertain the interactions of physiological (e.g., neural, musculoskeletal, immune) and psychological
systems in response to force-based interventions such as cOMM. Using TBI as a platform, the broad, long-term
objective of this study is to evaluate the neuro-biological effect of cOMM as a non-invasive approach to alleviate
symptoms and enhance neural tissue recovery. Using a preclinical model, we will investigate if cOMM can
mitigate behavioral patterns seen following repetitive closed head brain injury. We will use biomedical MR
imaging and molecular biology techniques to measure brain fluid flow and track inflammation with and without
cOMM treatment. Our study will include both males and females because it has been shown that neurological
symptoms, severity of injury and hence possibly changes in fluid flow in the brain are different between sexes,
which will allow refinement of cOMM treatment depending on sex. Collectively, we will be the first to provide
evidence for the clinically observed effects following cOMM when used as an intervention for TBI and resulting
acute and chronic symptoms.

Public health relevance
PROJECT NARRATIVE This research will contribute to fundamental knowledge regarding the mechanism by which cranial osteopathic manual manipulation (cOMM) enhances fluid flow in the brain and alleviates neurological symptoms after brain injury. Currently, there is a lack of mechanistic research on force-based interventions such as cOMM and there is limited data available on the brain’s response to this innovative treatment.